CIRCADIAN RHYTHMS IN PATIENTS WITH CHRONIC SPINAL CORD LESIONS

The purpose of this study is to examine how the daily light-dark cycle in the environment affects the timing of hormone release, the timing of the daily cycle of body temperature, the sleep-wake cycle, and inner body functions which ordinarily vary with the time of day.